Aging, sleep, and kynurenic acid

Advanced age presents challenges that increase the likelihood of poor quality and reduced
duration of sleep. Disruptions in sleep that come with aging may result in effects such as fatigue,
irritability, headaches, and deteriorating cognition. These disruptions are presumed to result from
alterations in brain regions that underlie endocrine, behavioral and cognitive responses to
homeostatic challenges in the organism. Unraveling common molecular mechanisms between
aging and sleep disturbances – which may lead to new therapeutic strategies to alleviate these
outcomes – is of great importance. Aging pathophysiology points to dysfunctional cholinergic
transmission, which may be driven, in part, by altered hypothalamic orexin neurons. We
hypothesize that kynurenic acid (KYNA), an endogenous antagonist of cholinergic
neurotransmission, plays a mechanistic role in age-related sleep dysfunction and orexin
activation. The small molecule KYNA is of particular interest because (i) KYNA and its
synthesizing enzymes kynurenine aminotranferases (KATs) are increased in the aging brain and
(ii) an excess of KYNA may be especially involved in sleep deficits that are seen with advanced
age. We propose the novel hypothesis that accumulated KYNA activates orexin neurons, thereby
disrupting sleep, a circumstance that is exacerbated with aging or a homeostatic sleep deprivation
(SD) challenge wherein KYNA accumulates in the brain. A specific inhibitor of KAT II, main
enzyme responsible for brain KYNA formation, will be used as an experimental tool to
mechanistically test the hypothesis. There are two specific aims to test our hypothesis. Aim #1:
To examine the relationship of KYNA to orexinergic activation in the lateral hypothalamus of
young rats (3-4 months) and old rats (26-28 months). Hypothesis: Accumulation of KYNA, as a
result of aging or acute sleep deprivation (SD), in the lateral hypothalamus activates orexin
neurons. Aim #2: To evaluate the impact of KYNA synthesis inhibition in improving sleep quality
in old rats and young rats with reduced orexin expression. Hypothesis: KAT II inhibition serves as
an efficacious strategy to overcome sleep architecture deficits in old rats and young rats with
reduced orexinergic signaling.

Public health relevance
With advanced age there is an increased likelihood of disturbances that impact the quality and quantity of sleep. Unraveling the underlying mechanisms that contribute to sleep disturbances in aging – which may lead to new therapeutic approaches to alleviate these outcomes– is of great importance. The following proposal is designed to test the novel hypothesis that kynurenic acid represents is a key molecular link between aging and sleep disturbances.